Lysosomal Metabolomics and pH

Abstract
Lysosomes are highly specialized and dynamic cellular organelles, which constitute an acidic environment in
the cell and are metabolic active by receiving and degrading macromolecules from the secretory, endocytic,
autophagic and phagocytic trafficking pathways. At the same time, lysosomes act as the signaling center of the
cell, and the metabolic status of the lysosome actively regulates nuclear transcription to govern various cellular
activities, such as cell growth, metabolism and quality control. Misregulation of lysosomal activity has been
associated with aging and age-associated diseases, including Alzheimer’s disease (AD). The Lysosomal
Metabolomics and pH Core (Core C) will support three Research Projects in this PPG proposal to assess
changes in lysosomal pH and metabolic activity through harnessing the power of high-throughput, high
accuracy Mass Spectrometry (MS)-based metabolomics and high-resolution fluorescence lifetime imaging
microscopy (FLIM). We will 1) perform lysosome-specific metabolomic profiling in aging and tauopathy mouse
models, 2) assess lysosomal pH changes using FLIM. In addition, Core C will carry both technological and
conceptual innovations by developing new technological platforms and by creating the first-in-class Aging- and
Tauopathy-associated Lysosomal atlas (ATLas) of the lysosomal proteome and metabolome for mouse cortex
and hippocampus in collaboration with Core A and Core B. Together, these studies will advance our current
knowledge regarding the association between lysosomal functions and aging and AD tauopathy and provide
powerful techniques and valuable resources to the fields of lysosomal biology, aging biology, and AD
pathology.